Supplement for Johns Hopkins Human Temporal Bone Resource

Research Summary Temporal bone research is essential for refining our understanding of the mechanisms of
otologic disease; however, the process is difficult, expensive, and requires expertise that only a small number of
active investigators have. In the parent award, we will make the Johns Hopkins human temporal bone collection
more accessible to the scientific community, re-establish the infrastructure for harvesting, imaging, and
processing new specimens, and develop teaching and outreach activities to increase engagement in human
temporal bone research. We partner with scientists specializing in biological visualization, bilingual scientific
communication, and mentoring diverse scientists to develop an inclusive, diverse scientific resource. Here we
propose a supplement to the Parent grant (Johns Hopkins Human Temporal Bone Resource) to support a
postdoctoral fellow who will work with our team to investigate methods for visualization and quantitative analysis
of the same temporal bones as intact structures, as thick sections for gross histological assessment, and as
semi- and ultrathin sections suitable for fine structure analysis using electron microscopy. For this supplement,
we will 1) optimize the temporal bone processing pipeline to enhance quality and resolution of morphological
data acquisition and 2) establish a workflow to analyze and correlate structural data derived from whole-organ
imaging down to ultrastructural microscopy. The tissue processing protocols and workflows to be developed will
enhance Aim 2 of the parent grant and will be useful for otopathology studies and assessing the
feasibility/histological side effects of potential hearing and balance treatments in human cadaver ears.
Additionally, the analysis protocols generated as part of this supplement will be useful in furthering our
understanding of how the 3D structure of the ear relates to functional measurements derived from audiometric
and vestibular tests. All protocols and analysis routines will be shared with the scientific community via the
website to be developed as part of Aim 3 of the parent grant. Sharing these tools will accelerate advances in and
knowledge of otopathology.

Public health relevance
Project Narrative Human temporal bone (ear histology) research is critical for advancing our understanding of the mechanisms of hearing and balance. The project will refine methods for contrast staining and imaging of newly obtained temporal bones and create a tissue processing and analysis pipeline for maximization of the information obtained from each specimen.